Cancer Data Talks in AI/AN/Native Hawaiian and Indigenous Landscapes

PROJECT SUMMARY/ABSTRACT
Cancer Data Talks in American Indian, Alaska Native, Native Hawaiian and Indigenous Landscapes is a project
that engages conversations with Indigenous community leaders, data experts, and thought leaders in cancer
data, through presentations, networking, and discussions focused on cancer control.

Public health relevance
PROJECT NARRATIVE The objective of this supplement is to advance knowledge in cancer data discussions in American Indian, Alaska Native, Native Hawaiian and Indigenous Landscapes. Discussions will include current surveillance, prevalence, incidence, and mortality patterns across populations with overall goals of understanding and utilizing data towards cancer control. Partners will engage in conversations on data as it relates to race, ethnicity, and Indigenous related classifications.